Enhanced Medical Rehabilitation for Late-Life Depression After Disablement

DESCRIPTION (provided by applicant): Elderly persons who have suffered a disabling medical event, such as a hip fracture, are likely to develop depression. Late-life depression (LLD) adversely affects acute medical rehabilitation, increasing the risk for persistent depression and disability. Existing acute medical rehabilitation settings — skilled nursing facilities (SNFs) and inpatient rehabilitation facilities (IRFs) — do not adequately meet the needs of depressed elders, resulting in a missed opportunity for affective and functional recovery. This R34 will develop enhanced medical rehabilitation for depressed older adults who are admitted to a SNF after a disabling medical event. The goal of this enhanced rehabilitative care is to reduce depressive symptoms and improve function. The intervention will consist of (1) high intensity PT &OT, and (2) comprehensive team-based management that incorporates mental health expertise. In this R34 we will develop enhanced medical rehabilitation in three stages: (1) develop a treatment manual;(2) pilot and iteratively modify the intervention;(3) carry out a preliminary randomized trial of the intervention in a SNF, with usual care comparison. The R34 is led by a multidisciplinary team with expertise in rehabilitation research and in mental health interventions in medical settings PUBLIC HEALTH RELEVANCE: Disabling medical events (such as hip fracture) occur approximately 6 million times per year in elderly persons in the US. There is a high incidence of late-life depression (LLD) in this context, which interferes with recovery from the medical event and increases functional dependence, institutionalization, and mortality. If successful, this proposal will have a significant public health impact, in that it will develop an effective nonpharmacological treatment for LLD that is applicable to the acute medical rehabilitation setting.

Public health relevance
Disabling medical events (such as hip fracture) occur approximately 6 million times per year in elderly persons in the US. There is a high incidence of late-life depression (LLD) in this context, which interferes with recovery from the medical event and increases functional dependence, institutionalization, and mortality. If successful, this proposal will have a significant public health impact, in that it will develop an effective nonpharmacological treatment for LLD that is applicable to the acute medical rehabilitation setting.